OpenMM: Scalable biomolecular modeling, simulation, and machine learning

PROJECT SUMMARY / ABSTRACT
OpenMM [http://openmm.org] is the most widely-used open source GPU-accelerated framework for biomolecular
modeling and simulation (>1300 citations, >270,000 downloads, >1M deployed instances). Its Python API makes
it widely popular as both an application (for modelers) and a library (for developers), while its C/C++/Fortran
bindings enable major legacy simulation packages to use OpenMM to provide high performance on modern
hardware. OpenMM has been used for probing biological questions that leverage the $14B global investment in
structural data from the PDB at multiple scales, from detailed studies of single disease proteins to superfamily-wide
modeling studies and large-scale drug development efforts in industry and academia.
Originally developed with NIH funding by the Pande lab at Stanford, we aim to fully transition toward a community
governance and sustainable development model and extend its capabilities to ensure OpenMM can power the
next decade of biomolecular research. To fully exploit the revolution in QM-level accuracy with machine-learning
(ML) potentials, we will add plug-in support for ML models augmented by GPU-accelerated kernels, enabling
transformative science with QM-level accuracy. To enable high-productivity development of new ML models with
training dataset sizes approaching 100 million molecules, we will develop a Python framework to enable OpenMM
to be easily used within modern ML frameworks such as TensorFlow and PyTorch. Together with continued
optimizations to exploit inexpensive GPUs, these advances will power a transformation within biomolecular
modeling and simulation, much as deep learning has transformed computer vision.

Public health relevance
PROJECT NARRATIVE Biomolecular modeling and simulation is a key technology for leveraging the $14B global investment in biomolec- ular structure data in the protein databank to understand the basic molecular mechanisms underlying biology and disease and the development of new therapies. In this proposal, we aim to expand the development of OpenMM, a free and open source biomolecular modeling and simulation package that can exploit a wide range of consumer-grade and high-end graphics processing units (GPUs) to enable researchers and applications built on OpenMM to achieve high performance with extreme ﬂexibility. A key aspect of this proposal is to accelerate research in the emerging ﬁeld of biomolecular machine learning by tightly integrating OpenMM with modern ma- chine learning frameworks, enabling researchers to build, use, and deploy machine learning potentials, collective variables, and integrators to advance the state of biomolecular modeling.